Administrative Core

Summary/Abstract
The Administrative Core is critically important for the smooth functioning of the Center Core activities.
To ensure consistent functioning of the Research Cores, the Core Staff assign schedules according
to the stated priorities of the Core. Scheduling conflicts are handled by the individual Core directors,
and if necessary, the Administrative Committee, which consists of the Module Directors, the Contact
Principal I Investigator, as well as an outside member. The Grants Manager/Administrator, Ms.
Whitney Thomas, will coordinate and manage all grant-related issues including daily management,
ordering, financial aspects of equipment maintenance, budget reconciliation, and progress report
preparation. She will also administer the iLab program, insuring that the Core participants and Core
personnel use the system appropriately. She will generate monthly reports for each Module, for the
benefit of the Module Directors in the PI.
References Cited Page 1